Neural and behavioral correlates of deliberate emotion regulation in early childhood: testing unique links to emerging irritability

7. Project Summary.
Irritability is a relative predisposition for angry responses to frustration that exists, at some level, in every
member of the population, but at the severe end is a symptom transversing the internalizing and externalizing
spectra and forecasting future mental illness. There has been increased interest in elucidating the specific
deficits that 1) discriminate early irritability that is and is not prodromal to mental illness, and 2) could be
reduced through novel intervention. Irritability is modulated by emotion regulation, which can be parsed into
non-mutually exclusive automatic (immediate, reactive) and deliberate (longer-unfolding, effortful) response
types. Deliberate emotion regulation, more so than automatic, requires greater prefrontal cortex activation and
engagement of executive function for successful implementation, and thus may be a better auger of irritability
severity and course and a more viable clinical target. However, deliberate emotion regulation is difficult to
measure in early childhood and has been under-researched.
The proposed Mentored Patient-Oriented Research Career Development Award will train the candidate to
probe deliberate regulation in preschoolers ranging from low to severe irritability, over a period of rapid
development, and connect findings to translational implications. The candidate's current expertise includes
differentiating the normal:abnormal spectrum of emergent psychopathology, with a focus on early disruptive
behavior, multivariate statistics, and some basic skills in acquiring and analyzing EEG and functional Near
Infrared Spectroscopy (fNIRS) data. To launch a translational program of research that connects a detailed
understanding of emotion regulation to emerging psychopathology and more effective treatments, the
candidate seeks advanced training in 1) a multi-level approach linking emerging emotion regulation with
irritability, 2) developing more refined treatment implications, and 3) longitudinal research. The candidate's
mentorship team, Drs. Perlman, Wakschlag, Huppert, Kolko, Molina, and Fox, provide expertise in child
neuroimaging, emotion regulation, and irritability, longitudinal design, and child treatment efficacy.
The proposed study will examine early deliberate emotion regulation, its association with level of
concurrent irritability, and changes in irritability, internalizing, and externalizing symptoms one year later.
Children ages 3 and 5 years (n = 50) ranging from low to severe irritability will complete a validated automatic
emotion regulation task followed by a novel deliberate emotion regulation task. An innovative multi-level
approach will be used to isolate deliberate from automatic emotion regulation by simultaneously recording
dorsolateral prefrontal cortex activation via fNIRS and facial expression via video. Children will complete the
paradigm again one year later and parents will rate their child's irritability, internalizing, and externalizing
symptoms at baseline and follow-up. The proposed study is designed to shift the field to focusing on deliberate
emotion regulation, inform future longitudinal work, and spur novel interventions for early irritability.
!

Public health relevance
8. Project Narrative. Severe irritability in preschool is a trans-diagnostic symptom associated with emerging psychopathology. There are major gaps in our understanding of deficits that differentiate irritable preschoolers who will and will not progress to mental illness and could form the basis of novel interventions. The proposed study examines deliberate emotion regulation as a potentially salient component of individual differences in current and future irritability that will inform future longitudinal and intervention work.